Single cell modeling of cancer mutations

ABSTRACT
Hundreds of thousands of mutations have been identified in cancer. However, the vast majority of cancer
mutations lack functional biological characterization. Therefore, very little is known about their impact on gene
function beyond in silico predictions. Developing experimental models to study the biological consequences of
these mutations is a daunting challenge. We developed a technology called transcript-informed single cell
CRISPR sequencing (TISCC-seq) that provides modeling of cancer mutations at single cell resolution. CRISPR
engineering introduces cancer gene mutations into cells. Single-cell RNA sequencing (scRNA-seq) is a power
tool for evaluating the genomic features of cancer. By combining these two approaches TISCC-seq has the
potential for dramatic increases in parallelization and scalability of experimental cancer models. We use DNA
base editors to introduce specific cancer mutations into target genes among individual cells. Single molecule
nanopore sequencing of the cDNA target directly identifies the mutation in each cell. By integrating single cell
long and short read sequence data, each cell’s newly introduced mutation is matched to the same cell’s gene
expression data. We will develop TISCC-seq as a new single cell genomic platform for engineering cancer
mutations into cell lines and primary tissue cultures.
Single base mutations are the most commonly reported type of cancer genetic alteration. For Aim 1, we will
develop TISCC-seq for highly multiplexed functional screening of substitution mutations at single cell resolution
while matching the mutation genotype to the same single cell’s transcriptome. We will identify reported cancer
mutations with known biological effects and others which are not characterized identified in colorectal or gastric
cancer. Next, we will determine which of these mutations can be engineered using base editing methods. Then,
we will deliver base editors and guide RNAs to engineer up to 500 substitution mutations across different cell
lines and organoids. Post-editing, the cells will undergo scRNA-seq with both short and long-read platform.
These data sets will be integrated to provide a single readout where the single cell mutation is matched to the
corresponding cell’s gene expression.
Alternative splicing is increasingly recognized as an important feature of cancer. Some cis-based cancer
mutations occur in exon-intron junctions that lead to alternative splicing of mRNAs. For Aim 2, we will develop
TISCC-seq as a method to evaluate this category of mutations. First, we will identify a set of 100 cancer genes
that have cis-based mutations at exon-intron junctions as reported in colorectal or gastric cancer. We will
increase the scalability of this process such that at least 500 of this class of mutations can be studied in parallel
using an integrated long and short read sequencing. These mutations will be introduced across different cell
lines and organoids. Overall, we will develop a new CRISPR genomic technology for highly multiplexed modeling
of cancer mutations at single cell resolution and studying their biological effects.

Public health relevance
NARRATIVE Specific errors, also referred to as mutations, in the genetic code of normal cells turns them into cancer. However, studying how these mutations cause a normal cell to become a cancer cell remains difficult. We have developed a new approach that enables one to study thousands of cancer mutations in a single experiment.